Gardner Lab MIRA Proposal: Microtubules and Mitosis

The Gardner Laboratory uses a combination experimental and computational approach to
dissect molecular mechanisms for how microtubule lengths are regulated inside of cells, and for
how force signaling acts to ensure proper chromosome segregation during mitosis. We use
biophysical computational modeling to better integrate and understand our experimental
observations, make new experimental predictions, and to test whether our proposed cellular
mechanisms are physically reasonable. Overall, we are a cellular biophysics laboratory that
combines cell biology tools with biophysical methods to shed new light on the regulation of
microtubule dynamics, and to dissect forces in mitosis. Achieving the goals described in this
application will provide mechanistic insights into how molecular-scale changes in microtubule
structure could regulate cellular-scale changes in microtubule-associated protein localization
and binding, as well as how changes in chromosome structure and stiffness could affect
cellular-level tension signaling during mitosis. In particular, this application will advance our
understanding of: 1) how microtubule structure can alter protein binding, and vice versa, 2) how
the cell reads out and responds to nuanced tension signaling during mitosis, and 3) how a
disease process such as cancer may alter tension signaling during mitosis, and the specific
impact of aneuploidy, which is a hallmark of cancer cells, on centromere stiffness and tension
signaling during mitosis.

Public health relevance
Mitosis is the process by which duplicated sister chromosomes are evenly distributed to identical daughter cells, and in cancer cells, improper chromosome segregation during mitosis (e.g., such that chromosomes are unevenly distributed between daughter cells) is widely observed, and has been linked to poor prognosis, including decreased overall survival time and fewer treatment free years. In this study, we will make use of physical principles and advanced microscopy to evaluate chromosome stiffness and tension inside of living cells, and to dissect the role of microtubule structure in the targeting of microtubule-associated proteins. The results generated from our studies will be applicable both towards better understanding the fundamental biophysics of cell division, and also towards providing mechanistic information to shed light on current cancer therapies.